The Human Foveal Connectome

The complex relationship of cone photoreceptor cells with retinal circuits, Müller glia, and retinal pigment
epithelial (RPE) cells is essential to normal vision. Yet for the cones in the very center of the fovea that mediate
peak visual acuity these relationships are poorly characterized. A longstanding barrier to a comprehensive
understanding of cellular and subcellular foveal structure is the myriad interactions among a great diversity of
cell types embedded and miniaturized within a complex three-dimensional architecture. The broad long-term
objective of this new research program is to elucidate foveal microstructure directly by application of new
methods of volume electron microscopy (connectomics). We will utilize retinal tissue acquired from an
innovative organ donor program that will permit pre-recovery optical coherence tomography (OCT) imaging to
assess retinal health status and foveal pit morphology and to guide connectomic reconstruction. Preliminary
data from two donor eyes demonstrates feasibility of complete reconstructions of foveal cones and their
associated synaptic pathways, Müller cells, and RPE cells. The first reconstructions of cone microcircuits from
an adult born preterm indicate that the critical cells and synaptic pathways for foveal vision differ dramatically in
structure and localization anticipated from previous work on non-human primates. Therefore in Aim 1 we
propose to localize, identify and reconstruct quantitatively the synaptic visual pathways that arise from
the central-most foveal cones. We will characterize all of the bipolar and ganglion cell circuits arising from
these cones and test the new hypothesis that the dominant “midget” pathway subserving spatial acuity may be
highly variable across individuals in both circuitry and pit localization. We will further test the hypothesis that
beyond the midget circuit the foveal center gives rise to over twenty distinct but as yet uncharacterized visual
pathways. The first reconstructions of Müller cells revealed the intimate wrapping of cone axons and
abundance of processes in the plexiform layer and foveal floor. In Aim 2 we propose complete
reconstructions of Müller cells to test the hypotheses that the foveal floor contains a novel Müller cell type
restricted to inner retina and that morphology of individual Müller cells and their foveal distribution accounts for
the macular pigment distribution. The first reconstructions of RPE cells provided new insights on the
distribution of organelles important in clinical OCT and autofluorescence imaging. Therefore, in Aim 3 we
propose to reconstruct and enumerate organelles in RPE cells in the cone-only fovea and the mixed
rod-cone perifovea. We will directly test the hypothesis that RPE organelle content and distribution differs
between cone-only fovea and rod-rich perifovea, accounting for the appearance of OCT bands and for
topography of autofluorescence signal in clinical imaging. This proposal combines expertise and innovation in
neurobiology, pathology, imaging, and connectomics. Outcomes will impact retinal neurobiology, clinical image
interpretation, and pathophysiology of macular diseases, especially age-related macular degeneration.

Public health relevance
The human fovea is essential for best vision but understanding the crucial cellular interactions among photoreceptors, neural circuits and supporting non-neural cells in the foveal center is limited because the extremely miniaturized and complex three-dimensional structure and synaptic organization of this region is difficult to untangle with conventional methods. The proposed project will apply new methods of volume electron microscopy (“connectomics”) to reconstruct the human fovea for the first time. Outcomes will have broad significance for retinal neuroscience, clinical image interpretation, and the pathophysiology of macular disease, especially age-related macular degeneration.